Targeting of B-AR/GBy signaling in the heart with small molecules

DESCRIPTION (provided by applicant): Heart failure (HF) is a debilitating disease with poor prognosis. Excess signaling through cardiac G-protein Gβγ subunits is an important component of HF pathophysiology. They recruit elevated levels of cytosolic G-protein coupled receptor kinase 2 (GRK2, bARK1) to agonist-stimulated b-ARs in HF, leading to the chronic b-AR desensitization and down-regulation that are hallmarks of HF. Previous data has suggested that inhibiting Gβγ signaling and its interaction with GRK2 could be of therapeutic value in HF. We recently developed a novel small molecule targeting strategy to selectively inhibit Gβγ binding interactions, and identified several Gβγ small molecule inhibitors (Bonacci et al, Science, 2006). In particular, compounds M119 and gallein, essentially identical in both structure and function, were found to block Gβγ -GRK2 interaction in vitro. Our preliminary data further demonstrate that they reduce GRK2 membrane recruitment, enhanced adenylyl cyclase activity, and increased contractility in isolated adult cardiomyocytes in response to b-AR agonist. In vivo, systemic delivery normalized cardiac function, morphology and GRK2 expression in an acute pharmacologic HF model. Importantly, daily treatment for one month halted the progression of HF and pathologic cardiac remodeling when administered to mice with established HF. Recent data demonstrates that elevated adrenal Gβγ -GRK2 signaling in HF leads to desensitization of adrenal a2-AR feedback inhibition of adrenal catecholamine release. These data suggest that simultaneous inhibition of both cardiac and adrenal Gβγ -GRK2 signaling could be of substantial therapeutic benefit in HF. Pathologic cardiac Gβγ signaling was recently found to interact with and result in novel, sustained ERK1/2 phosphorylation at T188; this sustained phosphorylation event has been directly associated with HF. Finally, Gβγ also signals to PI3Kγ, the only Gβγ - regulated PI3K. Large peptide disruption of either PI3Kγ activity or of PI3Kγ interaction with GRK2 and their recruitment to Gβγ is also known to normalize 2-AR signaling and cardiac function in HF models. We have now identified specific Gβγ inhibitory compounds that block Gβγ interaction with GRK2, PI3Kγ, or both. Our overall hypothesis is that selective small molecule targeting of Gβγ in the heart and in the adrenal gland is a novel therapeutic paradigm for HF, and that general and selective Gβγ compounds will enhance our current understanding of pathologic Gβγ signaling in the heart. To address this hypothesis, we propose the following specific aims: 1) Determine the efficacy and cardiac specificity of small molecule Gβγ inhibition in surgical models of HF. 2) Determine the adrenal role of small molecule Gβγ inhibition in HF. 3) Determine the role of Gβγ interaction with a novel ERK1/2 pathway, GRK2 or PI3Kγ in pathologic cardiac signaling, hypertrophy and cardiomyocyte contractility. In summary, we have exciting preliminary data identifying selective, bioavailable Gβγ inhibitory compounds that both prevent HF and halt HF progression. Experiments outlined in this proposal may provide a novel therapeutic strategy for HF.

Public health relevance
Project Narrative: Heart failure (HF) is a debilitating disease with poor prognosis. This proposal aims to investigate newly identified bioavailable compounds targeting an established HF pathway. Successful completion of experiments outlined in this proposal will enhance our current understanding of an established HF signaling pathway, and may provide a novel therapeutic strategy for HF.